AI enhanced lifetime-based mesoscopic in vivo imaging of tissue molecular heterogeneity

Abstract
Quantification of drug-target engagement is recognized as the most crucial parameter in the drug development
pipeline as it is central to therapeutic action. Though, such parameter can only be assessed via invasive
biochemical and immunohistochemical (IHC) approaches in ex vivo tissues. Herein, we propose to integrate and
optimize a multimodal optical imaging platform that can provide direct longitudinal (multiple time points)
measurements of the drug-target engagement distribution across the same tissue volume in correlation with drug
delivery efficacy parameters, including, tumor vasculature, and indicators of drug response, such as metabolism.
The imaging platform will be validated in human breast tumor and patient derived xenografts in live animals
subjected to HER2-trastuzumab therapy. Additionally, as MFMT is an indirect image formation technique relying
on complex computational tasks, we will further pioneer the use of Deep Learning methodologies for fast,
accurate, parameter-free and user friendly 2D and 3D MFMT image formation.

Public health relevance
Narrative A novel analytic preclinical longitudinal molecular imaging platform that can dissect and quantify intratumor heterogeneity at high-resolution in the context of targeted drug delivery will be developed. Fusion of lifetime- sensing and high-density fluorescence intensity imaging in the Short-Wave Infrared window will provide near cellular resolution maps of subcutaneous xenograft tumors and patient derived xenograft models. Vasculature and glucose metabolism datasets will be integrated with distribution of target engagement of well-known therapeutic antibodies to quantify intratumor heterogeneity at high-resolution in live, intact animals.